EXAMINATION OF THE EFFECT OF PRETREATMENT WITH MECAMYLAMINE

The goal of this proposal is to establish the relevance of central nicotini mechanisms to the cognitive disorder of Alzheimer's disease in elderly norm s.